ADPKD: Disease Spectrum & Genotype-Phenotype Correlations

Autosomal dominant polycystic kidney disease (ADPKD) is a common inherited disorder that results in
progressive renal insufficiency and often kidney failure and accounts for ~5% of US kidney transplant
and dialysis patients. ADPKD is phenotypically and genetically heterogeneous with seven genes now
associated with this disease, including the major loci, PKD1 and PKD2. Large patient populations
collected at Mayo Clinic have been central to new gene identification, and newly available populations of
normal individuals with whole exome sequencing and clinical data are providing insight into the
penetrance of ADPKD genes and alleles. In Aim 1, using these populations we will determine the extent
to which phenotypes within the ADPKD spectrum are dictated by novel genes, and explore the
penetrance of known alleles. Allelic diversity and complexity, especially for PKD1, has made diagnostics
for this disorder complex, with many patients not obtaining a definite genetic diagnosis following testing
using the existing variant evaluation guidelines; only variants of uncertain significance (VUS) are defined.
Functional, cellular assays and whole animal systems can help to determine pathogenicity and
penetrance of variants classified as VUS. In Aim 2 we will employ cellular and in vivo studies to determine
the mechanism(s) of disease causation for PKD1 and PKD2 pathogenic variants. These studies will
improve diagnostics and generate models that together will unravel the pathogenic mechanism of many
nontruncating variants and allow the associated disease to be modeled. Insights into the
pathomechanism of disease can also highlight new treatment options that are proximal to the primary
genetic defect, strategies that have been successful exploited for other monogenic disorders. Two variant
types in particular, missense changes that result in folding and trafficking problems, and nonsense
variants are common causes of disease in PKD1 and PKD2. In Aim 3 we will, explore allele-based
treatment options for ADPKD. Specifically, chaperone treatments will be tested for missense variants
where a folding/trafficking defect is the mutational mechanism, and the value of readthrough drugs for a
variety of PKD1 and PKD2 nonsense variants will be tested, both with cellular assays and in vivo systems.
Treatment options for ADPKD also depend on better understanding the mutational mechanism at the
level of the cyst; there has long been controversy in ADPKD about the importance and timing of somatic
second hits for cyst initiation and/or expansion. In Aim 4 we will investigate the role of somatic changes
in cyst initiation and development using single cell DNA sequencing methods. Overall, our proposal will
result in better understand the pathomechanisms associated with the genetic complexity of ADPKD, with
the premise that improved understanding will result in new targeted therapeutic options.

Public health relevance
Autosomal dominant polycystic kidney disease (PKD) is a common inherited disorder accounting for ~5% of the dialysis and kidney transplant population in the US. This grant seeks to determine new genetic causes of this disease, develop cellular and whole animal systems to determine the significance of variants found in genes causing ADPKD, explore treatment options that take advantage of increased understanding of the ADPKD mutational mechanism, and determine the importance of genetic events within cystic cells to disease development. These studies will result in a better understanding of the causes of ADPKD and improve diagnostics and treatment options.